Molecular and genetic decoding of neuron-glial interactions

Project Summary
Normal nervous system function depends on proper communications between neurons and non-neuronal cells.
In the human brain, the majority of non-neuronal cells are called glia that consist of nearly half of total brain cells.
Despite decades of work focusing on neurons and glia alone, how they communicate with each other remains
poorly understood. This is partly due to a dearth of methods to comprehensively profile molecules that are
enriched at the neuron-glial interface during dynamic cell-cell interactions. This proposal aims to develop a
genetically-guided proteomic toolbox to spatiotemporally profile critical molecules enriched at neuron-glial
interface in vivo, allowing for molecular and genetic dissection of neuron-glial interactions. We will first design
and generate glial-specific cell surface proximity-labeling probes with the spatiotemporal precision. We will apply
this platform in the oligodendrocytes, the sole myelin-producing cells in the central nervous system (CNS), to
determine the molecular mechanisms governing the initiation of oligodendrocyte-axon ensheathment. We will
leverage this new method, along with single-cell RNA sequencing, genome-wide CRISPR screens, and novel
transgenic mouse strains, to interrogate a mysterious cell stage (the pre-myelinating oligodendrocytes) during
developmental and adaptive myelination. To extend the glial surface proximity labeling toolkit, we will develop a
neuron-glial complementary proximity labeling system allowing for visualization of transient neuron-glial
interactions and capture of molecules only enriched at neuron-glial interface in vivo. Using this system we will
address the molecular codes governing myelination selectivity between subsets of oligodendrocytes and
functionally distinct neuronal subpopulations. This proposed work will fulfill the knowledge gap in myelin biology,
and will have broader implications in understanding neuron-glial and glia-glial interaction mechanisms in general.
The methods and reagents established by the work will also greatly enrich the methods in studying diverse cell-
cell communications, including neuro-immune and cancer-immune interactions.

Public health relevance
Project Narrative The major challenge in understanding how the brain functions is the lack of knowledge and tools in tackling neuron-glial interactions. The project aims to develop a method to profile critical molecules that mediate neuron- glial communications in vivo with the spatiotemporal precision. We will apply this method in oligodendrocytes and axons to understand the molecular mechanisms governing axon ensheathment and myelination selectivity.